UCI P30 Skin Center Administrative Core

The broad, long-term objective of the UC Irvine Skin Biology and Disease Resource-based Center is to
promote significant and innovative discoveries in regulatory mechanisms in skin biology and disease through
cross-fertilization between multiple disciplines, integrated through systems biology. The mission of the
Administrative Core is to centralize the leadership and operations of the Center, and to provide the
administrative support needed to meet the broad, long-term objective of the Center. The Administrative Core
will exert leadership for skin biology research at UCI and nationwide, and oversee outreach and enrichment
activities of the Center that will expand the community of scientists pursuing NIAMS-mission research. The
Center is led by Director Bogi Andersen and Associate Directors Anand Ganesan and Arthur Lander, with
input from the Executive and Advisory Committees. The Administrative Core will manage funds and other
Center activities; oversee communications; set milestones and oversee surveys and other methods of
evaluations; oversee programs for Diversity, Equity, and Inclusion; and oversee Community Engagement
efforts. The Administrative Core also runs a series of programs of enrichment, including weekly Skin Club,
monthly seminar series, and yearly symposia, as well as several mechanisms for seed grant and other
funding types that advance the specific aims of the Center in the upcoming cycle. In the first cycle, the Center
Administration successfully enhanced collaborations and synergy among research community members, and
attracted new researchers to the study of skin biology and disease. The initial funding of the Center spurred
a marked increase in technology development, innovative research publications, and grant funding. By
servicing the various needs for the three resource Cores and the P30 research community members, the
dedicated effort and strong support of this centralized Administrative Core provides added value and
enhances the synergy of the research community of the UC Irvine P30 Center.